Neuroproteomics Core - Yates

PROJECT SUMMARY
The Neuroproteomics Core of The Scripps Research Institute Alcohol Research Center (TSRI-ARC) will provide
mass spectrometry-based bioanalytical collaborations to meet the specific needs of the TSRI-ARC and Center-
at-Large. Given the breadth of work to be conducted in this translational research center, it is understandable
that not all personnel will have expertise in specialized areas of analytical chemistry. The first goal of the
Neuroproteomics Core is to provide access to proteomic methods, such as protein expression analysis,
phosphoproteomics, protein interactions, and biorthogonal chemistry, for the discovery of molecular mechanisms
in animal models of alcohol drinking and dependence to TSRI-ARC investigators. Personalized consultation with
investigators on issues related to experimental design, sample collection, sample handling, and data
interpretation will be provided. The second goal of the Core is to advance methods to perform single-neuron
proteomic measurements in combination with electrophysiology measurements to study alcohol use disorder
(AUD). In all these experiments, Core personnel will work closely with TSRI-ARC investigators to solve technical
problems and assess and analyze the data.